Multi-Radical Protein Footprinting (MRPF™) Platform

The GenNext Phase II SBIR submssion entitled “Multi-radical Protein
Footprinting (MRPF™) Platform,” is responsive to the ackowledged need for new and
improved tools for higher order structural analysis (HOS) of biopharmaceuticals and
membrane protein target studies. An emerging HOS analysis technique is radical foot-
printing (RPF). RPF involves the irreversible labeling of a protein’s exterior by reaction
with radicals with subsequent MS analysis to identify the outer portions of the protein.
We have developed commercial solutions to perform Hydroxyl Radical Protein
Footprinting (HRPF) employing OH radicals known as the Fox® Protein Footprinting
System. A new RPF technique that relies upon trifluoromethyl (TFM) radicals created
by •OH attack of aqueous sodium triflinate has been developed. TFM protein footprinting
(TFMPF) is highly complementary to HRPF. When used together, HRPF and TFMPF
provide improved spatial coverage than either alone.
In our phase I program, we created a facile means to assess effective radical
load during CF3 labeling experiments by creating an in-line fluorescence detector that
measured the photometric response of coumarin-based internal standard radical
dosimeters to •OH and •CF3 attack. In our Phase II program, we build upon our phase I
success to create a pre-commercial system that will enable selectable •OH or
simultaneous •OH and •CF3 labeling, with in-line radical dosimetry, and optimized data
processing software. In doing so, we will extend our products to also support TFMPF,
creating a powerful and impactful improvement to biopharmaceutical HOS.
GenNext Technologies is the world’s only company commercializing instruments
and solutions for RPF HOS analysis. Our overarching goal is to convert the RPF process
from an academic research experiment into a broadly adopted and valuable HOS
analytical tool. We firmly believe that our proposal will significantly impact HOS analysis
with transformative benefits to biopharmaceutical research.

Public health relevance
The importance of biopharmaceuticals and membrane protein targets has created a need for improved analytics to facilitate biopharmaceutical research. Our Phase II SBIR proposal will create a needed instrumentation means to study the higher order structure of membrane protein targets as well as other biopharmaceutical drug targets, facilitating proteomics and pharmaceutical research and development. Upon successful completion of our program, we will demonstrate the transformative nature of our new technology to positively impact biopharmaceutical research.